Evaluating the tuberculosis epidemic in South Africa using a novel ten-year cohort

Project Summary:
Tuberculosis (TB) is the leading cause of infectious disease deaths globally. With TB incidence
currently decreasing by 2% annually, achieving the World Health Organization’s ENDTB goal
of TB elimination by 2050 will require a substantial reworking of our TB control approach.
Previous elimination strategies for other diseases have only been successful once spatial
variation in disease incidence was identified and then locally relevant interventions
implemented. TB elimination strategies require longitudinal TB cohorts that incorporate
detailed spatial information. South Africa is an ideal setting for our work with both the second
highest TB incidence globally and a central National Health Laboratory Service (NHLS)
database of routinely-collected laboratory results. We propose to develop a ten-year national
TB cohort with the ability to track patients for up to ten years, including spatial location data
and HIV status, using national NHLS data. We hypothesize that NHLS data can be used to
identify key metrics in the TB care cascade, at the facility level, and evaluate the impact of HIV
treatment scale-up and the roll-out of new diagnostics on the TB epidemic in South Africa. In
aim 1a we will use probabilistic record linkage to create unique patient identifiers in the NHLS
data for all TB patients, allowing us to link an individual’s test results and track those confirmed
cases spatially and temporally, and incorporating HIV test results. In aim 1b, we will identify
key steps in the TB care cascade and augment our ten-year cohort with data from clinic chart
reviews. In aim 1c, we will identify locations with gaps in specific care cascade steps, common
patient movement patterns during TB treatment and identify locations with potential higher
burden of disease based on molecular test variables. In aim 2 we will quantify the relationship
between HIV treatment levels and TB incidence, at the facility level. In aim 3 we will evaluate
the association between GeneXpert Ultra “trace” results and repeat TB episodes to enhance
the interpretation of these new diagnostic results. This contribution is significant because it will
develop a national ten-year cohort of TB patients tracking them longitudinally and spatially
during treatment, enabling local public health professionals to develop locally appropriate
interventions to close gaps in the TB care cascade and understand the impact of interventions
and new TB diagnostics. The proposed work is innovative because it will provide the first
cohort of this kind in a high burden setting, with the longitudinal and spatial nature of these
data allowing for unprecedented capture of TB care and the impact of interventions. This will
allow policy makers to design locally-relevant interventions targeting specific gaps in TB care
and highly mobile populations, preventing further spread and ultimately reducing disease and
mortality due to TB. By using routinely collected laboratory data, our model adds minimal
financial costs and can be adapted for similar TB high-burden, middle-income settings with
large laboratory datasets.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will provide a framework to use routinely collected South African laboratory data to track tuberculosis (TB) patients through time and space, incorporating HIV data. This will allow us to define the TB care cascade nationally and by facility (clinic/hospital), incorporating patients’ movements, thus enabling the targeting of these locations with locally appropriate interventions. We will also be able to evaluate the impact of HIV treatment scale-up and introduction of new TB diagnostics on TB morbidity and mortality – directly relevant to the NIH’s mission of reducing morbidity and mortality due to tuberculosis.